Admin Core

PROJECT SUMMARY - ADMINISTRATIVE CORE
The overarching goal of the Health-First Climate Action Research Center, a Wisconsin-based Climate Change
and Health Research Center (CCHRC), is to catalyze rigorous, innovative, community-driven, policy-relevant,
transdisciplinary research on health and equity impacts of specific energy choices as the US strives to reach a
low-carbon energy transition. Achieving this goal requires effective coordination and communication, evaluation,
and a plan for sustainability beyond the initial 3-year funding period. The Administrative Core will serve that
need by coordinating, administrating, evaluating, and sustaining all components and processes of the CCHRC.
This goal will be achieved through five Specific Aims: (1) Coordinate interaction and integration across the Cores,
Research Projects, and activities of the Center, (2) Create an effective administrative structure for successful
governance and clear decision-making, (3) Establish and administer a Pilot Grants Program to support pilot
initiatives and expand research capacity, (4) Establish and convene a transdisciplinary, cross-sector External
Advisory Committee to guide overall direction and strategic decision-making, and (5) Conduct thorough and
iterative evaluation of all activities, processes, outcomes, and impacts of the research center, with a focus on
equitable community engagement, transdisciplinary integration, and a health-first approach. The
Administrative Core team includes a Director and Deputy Director, both accomplished leaders in climate change
and health research with extensive leadership experience; a co-investigator with experience in air pollutant
impacts on children; and staff with expertise in transdisciplinary team science, community engagement,
evaluation, climate science communication, and team coordination. Administrative Core team members will
leverage several innovative strengths to increase the capacity and impact of the CCHRC, including distributed
leadership across academic institutions and community and policy groups; integration of diverse perspectives
through activities such as voting rights to community members regarding the Center’s activities and direction; a
multisector, transdisciplinary approach that integrates and builds upon expertise across disciplines and sectors;
and structures such as the Pilot Grants Program, External Advisory Committee, Evaluation Partnership Team,
and Community Advisory Board to maximize the team’s ability to conduct and disseminate results of innovative,
meaningful, policy-relevant research. The Administrative Core team will support, facilitate, and evaluate
research aimed at maximizing health and equity impacts of energy and transportation policies and choices. All
administrative activities will include processes and plans for multidirectional communication and learning that
enable iterative improvement and midcourse correction when needed. Through these activities and structures,
the Administrative Core will promote integration across scientific disciplines, community partners, and
collaborating institutions to facilitate maximum effectiveness of this innovative, community-engaged, equity-
driven, transdisciplinary CCHRC.

Public health relevance
PROJECT NARRATIVE Project Narra�ve is located in the Overall Component.